Clinical Phenotyping and Human Core

PROJECT SUMMARY CORE B
Lower respiratory tract infections cause nearly 80% of deaths from infectious diseases in the US, and respiratory
viruses, such as influenza and SARS-CoV-2, are increasingly recognized as common causes of severe
community-acquired pneumonia (CAP). As mortality from severe CAP persists despite appropriate
antimicrobial treatment and clearance of the causative pathogen, Program Project Investigators hypothesize
that mortality and persistent organ failure in severe viral CAP represent persistent inflammatory injury and a
failure of lung repair mechanisms. Persistent inflammation and unrepaired organ damage drive poor long-term
outcomes following severe CAP, and biomarkers suggest that patients with poor outcomes from severe CAP
have a persistent pro-inflammatory state despite clearance of the presumed pathogen. Core B will allow Project
Investigators to validate findings from causal murine and cell models of influenza pneumonia in patients with
severe CAP induced by viral pathogens. The major goal of Core B is to provide serial bronchoalveolar
lavage (BAL) samples obtained from well-phenotyped patients with severe influenza and SARS-CoV-2
pneumonia to the Project Investigators, as defined in the following Specific Aims: 1) Provide BAL fluid
from intubated patients with influenza and SARS-CoV-2 pneumonia for a) flow cytometry-sorted BAL alveolar
immune cell subsets for transcriptomic and epigenomic analysis and b) cell-free supernatant fluid for
metabolomic and biomarker/protein analyses. 2) Define the microbiologic milieu at each BAL sampling time
point regarding a) the presence of viral pathogens (viral PCR), b) the presence of bacterial co-infection (culture
and PCR), and c) microbiome alterations. 3) Apply robust clinical phenotypes and relevant clinical endpoints.
Core B will leverage the existing infrastructure of the Successful Clinical Response In Pneumonia Therapy
(SCRIPT) Systems Biology Center at Northwestern University and its rigorous published protocols for flow
cytometry sorting of alveolar immune cell populations, microbiologic analysis, and clinical phenotyping.
Ultimately, the goal of this PPG is to define immune system pathways and mechanisms of failed resolution and
repair following influenza and SARS-CoV-2 pneumonia that are amenable to therapeutic interventions. Core B
is integral to supporting this goal by demonstrating strong clinical correlations to findings from the proposed
murine models.

Public health relevance
PROJECT NARRATIVE It is not required per instructions stated on the Funding Opportunity Announcement PAR-18-405, Section IV. Application and Submission Information, Scientific Core, Research & Related Other Project Information (Scientific Core), “Project Narrative: Do not complete.”